Burden of Late-Pre term Births throughout the First Year of Life

DESCRIPTION (provided by applicant): Summary More than 70% of preterm infants are born between 34 and 36 completed weeks of gestation or late preterm. This is the equivalent of 8% of all infants born in the United States each year. These infants are at increased risk for morbidity and mortality in the perinatal period and are twice as likely to die in the first year of life. Despite this, only preliminary research has been done to explore the morbidity of these infants in the first year of life. Overarching hypothesis: Late preterm infants are at increased risk for morbidity beyond the perinatal period. Specific Aim 1: Describe the incidence and risk factors for late preterm delivery in a sociodemographically-diverse population using private and public administrative claims data linked to birth certificate records. Hypothesis: Race and socioeconomic status are independent risk factors for late preterm delivery. Dr. Halloran will link birth certificate records to private and public insurance claims data. She will describe the incidence and risk factors for late preterm birth among a racially- and economically-diverse group to increase the understanding of the inadequately-defined epidemiology of late-preterm births. Specific Aim 2: Evaluate cause-specific and gestational-age-specific morbidity in late preterm and term infants over the first year of life, specifically respiratory-related conditions. Hypothesis: Late preterm infants are twice as likely to have respiratory diagnoses, respiratory-related medication use, and respiratory-related hospitalizations compared to term infants. Dr. Halloran will characterize the association of gestational age with respiratory complications including respiratory-related diagnoses, inpatient/outpatient health care utilization, and medication use in late preterm versus term infants. Specific Aim 3: Determine the difference in cost of infant care in late preterm versus term infants in the first year of life using population-based data which includes private and public claims data linked to birth certificate records. Hypothesis: Late preterm infants have at least 100% increase in total cost of care during the first year of life compared to term infants. Dr. Halloran will examine the total cost (inpatient, outpatient, and prescription drugs) and system-specific cost in late preterm versus term infants throughout the first year of life. Following a research fellowship and Masters of Science in Public Health, Dr. Halloran is on the tenure-track in the Division of General Pediatrics at St. Louis University (SLU). She has chosen a multidisciplinary panel of mentors with expertise and experience in maternal-fetal medicine, neonatology, health services research, health economics, and biostatistics. This committee in combination with the support of the SLU School of Medicine, SLU School of Public Health, and Washington University Institute of Clinical and Translational Science will provide her with a strong research environment. Through advanced statistical training as part of a PhD in Outcomes Research and the mentorship of a diverse, experienced group of mentors and advisors, Dr. Halloran will be well-positioned to become an independent investigator in infant outcomes research.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal will lead to the development a risk-based system to sub classify the heterogeneous category of late-preterm infants and improve the precision of risk assessment in this population. This project will lay the groundwork for future studies designed to improve the health of late preterm infants who account for 8% of all infants born in the US each year - through additional prospective research or interventions. It will provide the training and experience necessary for Dr. Halloran to become an independent investigator in infant outcomes research. Project Narrative This proposal will lead to the development a risk-based system to subclassify the heterogeneous category of late-preterm infants and improve the precision of risk assessment in this population. This project will lay the groundwork for future studies designed to improve the health of late preterm infants who account for 8% of all infants born in the US each year - through additional prospective research or interventions. It will provide the training and experience necessary for Dr. Halloran to become an independent investigator in infant outcomes research. __SpecificAimsTextDelimiter__ 10. Specific Aims Statement of Hypothesis and Specific Aims Overarching Hypothesis: Although late preterm infants are known to be at increased risk for postneonatal mortality, few studies have examined the morbidity of such infants throughout the first year of life. We hypothesize that late preterm infants are at increased risk for postneonatal morbidity. Aim 1: Describe the incidence and risk factors for late preterm delivery in a sociodemographically- diverse population using private and public administrative claims linked to birth certificate records. Hypothesis: Race and socioeconomic status are independent risk factors for late preterm delivery. More than 70% of preterm infants are born between 34 and 36 completed weeks of gestation (late preterm).2,3 As such, increased morbidity and mortality in this population is arguably the most important public health concern in this population. We will combine data from three sources in order to improve our understanding of the inadequately-defined epidemiology of late preterm birth. Currently, we have linked claims data from Blue Cross Blue Shield of Missouri, the WellPoint licensee for the State of Missouri and the largest private payer in the State, to birth certificate records through the Missouri Department of Health and Senior Services. We are in the process of linking Missouri Medicaid claims data to birth certificate records. The study will include claims from more than 10,000 late preterm and 100,000 term infants covered by either private or public administrative claims. Describing the incidence and risk factors for late preterm birth, especially among a racially- and economically-diverse group, will provide the foundation for estimates of overall burden of this population. We will include inadequately explored risk factors such as level of hospital care at birth, socioeconomic status, and payer status. Aim 2: Evaluate cause-specific and gestational-age-specific morbidity in late preterm and term infants, specifically respiratory-related conditions. Hypothesis: Late preterm infants are twice as likely to have respiratory diagnoses, respiratory-related medication use, and respiratory-related hospitalizations compared to term infants. Late preterm infants have been shown to have increased respiratory morbidity in the perinatal period including transient tachypnea of the newborn, respiratory distress syndrome, and pneumonia.4-13 The cause-specific morbidity in late preterm infants throughout the first year of life, however, remains incompletely described. Using the databases described for Aim 1, we will characterize the association of gestational age with respiratory complications throughout infancy including reactive airway disease/asthma, bronchiolitis, pneumonia, and respiratory failure. We will examine the relative risk of specific respiratory complications in late preterm versus term infants beyond the perinatal period by determining rates of specific conditions/diseases such as pneumonia and bronchiolitis. We will then determine the rate of respiratory-related medication use in late preterm versus term infants. Finally, we will assess health care utilization (inpatient and outpatient) for respiratory-related diagnoses. Aim 3: Determine the difference in cost of infant care in late preterm versus term infants, using population-based data which includes private and public claims data linked to birth certificate records. Hypothesis: Late preterm infants have at least 100% increase in total cost of care during the first year of life compared to term infants. [Multiple studies have documented an increase in perinatal health care costs for preterm infants, including late preterm.14,15 However, studies have only begun to explore the persistence of increased costs beyond the perinatal period. The extent to which late preterm infants remain an increased burden on society through the first year of life is dependent, at least in part, on the potential increased cost associated with their care. Given the large number of late preterm infants born in the US each year (more than 335,000 in 2005), even small increases in cost may result in large total costs for the population. We will determine the total cost of care and system-specific cost of care for inpatient services, outpatient services, and prescription drugs in late preterm versus term infants through the first year of life.]